Reward Sensitivity as a Mechanism of Positive Affect Treatment for Anhedonia

PROJECT SUMMARY
Anhedonia, or loss of interest or pleasure in usual activities, is characteristic of depression, some types of
anxiety, as well as substance abuse and schizophrenia. Anhedonia is a predictor of poor long term outcomes,
including suicide, and poor treatment response. Extant psychological and pharmacological treatments are
relatively ineffective for anhedonia. Thus, there is an unmet therapeutic need for this high-risk symptom. Recent
advances in affective neuroscience have elucidated processes that may underlie anhedonia and should be
targeted in therapy. Specifically, anhedonia is associated with deficits in the appetitive reward system, including
(1) reward approach-motivation, (2) initial responsiveness to reward attainment, and (3) learning of reward. We
have developed a novel transdiagnostic psychosocial treatment for anhedonia, Positive Affect Treatment (PAT),
designed to improve deficits in reward sensitivity. In our pilot study of 61 depressed or anxious and functionally
impaired individuals we found a strong preliminary efficacy signal and evidence for treatment specificity.
Specifically, PAT led to significant improvements in symptoms of anhedonia, depression and anxiety and was
more effective for individuals with anhedonia at baseline than a treatment designed to reduce negative affect.
The proposed application uses an experimental therapeutics approach to elucidate whether reward approach-
motivation, initial responsiveness to reward attainment or reward learning change with PAT (i.e., target
engagement) in the R61 phase, and to evaluate whether changes in reward sensitivity mediate outcomes from
PAT in the R33 phase. In the R61 phase, 68 individuals with anhedonia who are anxious or depressed and
functionally impaired will be randomized to single-dose PAT (15 weekly sessions) or double dose PAT (PAT-
DD, 30 twice-weekly sessions). Physiological, behavioral, and self-report measures of reward approach-
motivation, initial reward responsiveness, and learning will be assessed repeatedly. Outcomes include clinician
and self-report measures of anhedonia and ecologically valid measures of functional impairment (i.e., physical
activity and social interaction). Progression to R33 depends on post-treatment average anhedonia scores that
are within 1 SD of the norm, and significant (effect size > .8) pre- to post-treatment changes in reward approach-
motivation, initial responsiveness to attainment or learning, which covary significantly with anhedonia over
treatment. The treatment dose that produces significantly greater pre- to post-treatment change in one or more
target measures will be carried forward to R33. In the R33 phase, 100 individuals will be randomized to PAT (or
PAT-DD) or to Negative Affect Treatment; the latter designed to reduce threat sensitivity. Indices of reward
sensitivity (from R33 phase) and threat sensitivity will be evaluated as mediators of PAT and moderated
mediation will be tested by comparing reward sensitivity mediation in PAT vs NAT. If successful, PAT will offer
a viable and effective treatment for individuals with anhedonia, and the results will elucidate the mechanisms
responsible for the effectiveness of this novel treatment.

Public health relevance
NARRATIVE This study addresses an unmet therapeutic need for anhedonia, a high-risk symptom for which existing treatments have been largely ineffective. We propose to test a novel psychosocial treatment for anhedonia, Positive Affect Treatment, which is thought to directly target core deficits in reward processing (reward approach-motivation, initial responsiveness to attainment, and learning). If successful, Positive Affect Treatment will provide a viable treatment option for individuals with anhedonia, and the results will elucidate the mechanisms responsible for the effectiveness of this novel treatment.